Administrative Core A

SUMMARY
The Administrative Core is located within the administrative offices of the Blood Research Institute, the
research arm of Versiti Blood Center of Wisconsin, and serves as the focal point for the administration of the
Program Project. The Administrative Core will provide coordinated, centralized support for the participants of the
Program, including the Project Leaders and Core Directors. The Administrative Core has several specific
functions: (1) To provide scientific leadership through the combined efforts of the Principal Investigator and the
Executive Committee and External Advisory Committees; (2) To maintain and coordinate the physical facilities
utilized by the Program, i.e., space and equipment; (3) To execute administrative and budgetary functions; (4)
To organize, coordinate and document regularly scheduled scientific and administrative meetings of the Program
Project leaders; and (5) To organize and coordinate meetings of the Internal and External Advisory committees.
These administrative functions will be carried out under the direct supervision of Peter J. Newman, Ph.D.,
Program Director, Senior Investigator of Versiti's Blood Research Institute and past Vice President for Research
at Versiti Blood Center of Wisconsin.